A Daily, Digital Mindfulness-Based Intervention for Depressive Symptoms After Serious Illness

ABSTRACT
Depression is highly prevalent among people with serious medical illness, like cancer, and is associated with
adverse outcomes, including worse disease course and increased disability and mortality, making
management of depressive symptoms in medically ill populations a priority. Patients who recently completed
treatment for cancer, a challenging adjustment period for many, are at especially high risk for experiencing
depressive symptoms, that when left unaddressed, confer risk for recurrence and earlier mortality.
Mindfulness-based interventions (MBI), like Mindfulness-based Cognitive Therapy (MBCT), effectively reduce
depressive symptoms in cancer survivors. However, because most MBIs are group-based, time intensive,
difficult to scale, and can be costly, only a small portion of patients ever engage with MBIs. Of those that do,
adherence to at-home practice is suboptimal in cancer survivors, an indication that currently prescribed daily
practice dosages may not be feasible or accepted by this population. Thus, to increase reach, scalability,
feasibility, and acceptability of MBIs for depressive symptoms in post-treatment cancer patients, a new
approach is needed. The candidate will address this need by adapting core components of MBCT-Brief (an
abbreviated version of MBCT) into a novel, daily, digitally delivered format: 15 minutes of audio content
delivered via text message daily for 8 weeks. First, the candidate will develop the daily Mindfulness-based
INtervention for Depressive symptoms SEnt via Text (MINDSET) for post-treatment cancer patients. Then, the
candidate will conduct a single-arm pilot study to test and refine MINDSET using participant feedback via a
mixed methods approach (i.e., quantitative survey and qualitative focus group data). Finally, the candidate will
conduct a randomized controlled trial to test the feasibility and acceptability of MINDSET and the control
condition (Enhanced Usual Care). Findings from this research will provide data for an R01 application to
conduct an adequately powered randomized controlled trial to test the efficacy of MINDSET in reducing
depressive symptoms. The proposed Mentored Patient-Oriented Research Career Development Award (K23)
will provide the candidate with training and hands-on experience in 1) adapting an evidenced-based
intervention for depression digitally; 2) conducting qualitative and mixed methods research; and 3) clinical trial
design and conduct, skills that the candidate needs to conduct high-impact rigorous research in integrative
health interventions. The candidate will carry out the proposed training and research in an outstanding
research environment under the guidance of an exceptional team of mentors, advisors, and consultants who
are experts on these topics and are dedicated to her career development. The proposed award will provide the
candidate with the in-depth experiences needed to establish an independent program of patient-oriented
research focused on whole-person integrative health interventions, including those for depression and common
serious medical illnesses, like cancer.

Public health relevance
NARRATIVE Depression is a key contributor to the current mental health crisis, and non-pharmacologic treatments are not suited to scale to the current demand. This project aims to improve accessibility and scalability of an evidence- based approach to depressive symptom management in a high-risk population, cancer survivors.